Administrative Core

Project Summary (Administrative Core)
The Administrative Core will serve as the central hub of this geographically distributed U19 team. It will monitor
progress, promote exchange of results and technology by organizing monthly and quarterly team video-
conferences and annual face-to-face meetings. To provide oversight and critical feedback, it will organize
annual meetings with the External Advisory Board. The Core will establish a pipeline for shipping sequencing
samples from Projects 1, 3, and 4 to the Genome Technology Center of NYU School of Medicine. The
Administrative Core will also coordinate the transfer of sequencing data from NYU School of Medicine back to
the projects and Data Science Core. The Core will provide financial and regulatory management to ensure
compliance with federal and institutional rules and budgetary oversight. In addition, it will provide support for
scientific communications and implement and support a program web site to disseminate information, tools,
and data to the broader neuroscience community.